Administrative Core

ABSTRACT – ADMINISTRATIVE CORE (CORE A)
The Administrative Core (Core A) will be the central hub of the National Center for Translational Research
in Infertility and Reproduction (NCTRI) at UCSF. Located in the UCSF Center for Reproductive Sciences
(CRS) administrative office, in close proximity to our proposed NCTRI laboratories and members, Core A
will provide administrative support for the investigators and technical staff engaged in our Center’s research
projects and will provide the infrastructure to establish the Center’s Pilot Projects. It will maintain the NCTRI
website and will organize and support the monthly Steering Committee meetings, Scientific Advisory Board
meetings, and participate in the planning of the annual UCSF CRS retreat that serves as an opportunity to
share research advances and identify and nurture new talent. Day-to-day operation of the Administrative
Core will be under the direction of Center Director/PI Adrian Erlebacher, M.D., Ph.D., assisted by Core A
Associate Director Linda Giudice, M.D., Ph.D. who have complementary and extensive experience in basic
and translational investigation, with Dr. Giudice providing her expertise in administering large, complex,
multi-disciplinary research programs. They will oversee the Core A Program Administrator and will liaise
with the Administrative and Finance team of PI Erlebacher’s home department, Laboratory Medicine, that
will assure financial and research compliance aspects of the award, ensuring expenditures are consistent
with the intent of the award and the guidelines and regulations that govern the use of funds, as well as any
institutional and federal requirements, so that Projects and Core goals are met.